MyPrEP Plus: Development and Pilot Testing of Novel Pre-Exposure Prophylaxis Support Tools for Transgender Women

Project Summary/Abstract
Transgender women (TGW) are the population with the highest prevalence of HIV infection in the
United States (US), with increasing numbers of new diagnoses from 2015-2019. Three types of pre-exposure
prophylaxis (PrEP) have been shown to be highly effective in TGW, but uptake remains low in this population.
TGW face a number of barriers in taking up and staying on PrEP, including pill fatigue from taking PrEP and
hormone pills, concerns about reduced efficacy of gender-affirming hormones when taking PrEP, and concerns
that PrEP works only for men who have sex with men (MSM), among other barriers. Many of these barriers
could be alleviated by additional information or by choice of a different regimen. Decision support tools can be
a useful adjunct to patient-led decision-making; a PrEP decision aid for cis-gender women in South Africa
doubled PrEP uptake. We are adapting this tool (MyPrEP) for use in US English- and Spanish-speaking TGW.
However, TGW likely need additional help in starting PrEP; therefore, we are combining MyPrEP with our
bidirectional SMS communication tool (PrEPmate), the first CDC-endorsed evidence-based PrEP support tool
shown to double PrEP adherence in young MSM. PrEPmate has already been adapted for TGW, but the PrEP
navigation component of the tool has not fully incorporated addressing some of the social determinants of
health that are barriers for TGW using PrEP. Therefore, in Aim 1, we will explore features of different PrEP
modalities that are of greatest value to TGW and examine social determinants that may pose barriers to
engaging in PrEP, through the use of formative research. We will conduct 6 focus groups in TGW (3 in English,
3 in Spanish, 5-7 TGW each) and conduct interviews with 8-10 PrEP providers for TGW, to explore these
themes. Then, in Aim 2, we will adapt the MyPrEP patient-facing decision support tool for English- and
Spanish-speaking TGW using iterative focus groups (2 in English, 2 in Spanish, 5-7 TGW each). These focus
groups will meet 3 times over 3 months to provide input into the MyPrEP website for TGW, and to ensure it is
culturally and linguistically appropriate for both English- and Spanish-speakers. Finally, in Aim 3, we will
conduct a pilot randomized controlled trial with 40 TGW randomized to receive the combination of MyPrEP with
PrEPmate (MyPrEP Plus), and 20 randomized to receive the control condition (pleaseprepme.org website).
The RCT will evaluate the feasibility of MyPrEP Plus use (measured by use of both component tools) and
compare the acceptability and PrEP uptake of MyPrEP Plus versus pleaseprepme.org. At the end of the
MyPrEP Plus studies, we will have adapted MyPrEP Plus for English- and Spanish-speaking TGW, and will
determine whether it holds enough promise to move forward into a fully powered, multi-site RCT in TGW to
assess its impact on PrEP uptake, adherence, and persistence.

Public health relevance
Project Narrative Anti-HIV medications (pre-exposure prophylaxis or PrEP) can protect against HIV infection, but few transgender women are using PrEP. This project will adapt a patient-based website to help transgender women choose the form of PrEP that would work best for them, and will test this website in addition to an SMS communication tool, to see if the combination is feasible, acceptable, and if it improves PrEP use over 3 months. If successful, the next step will be to test the combined tool (MyPrEP Plus) in a large trial of transgender women to see if it helps PrEP use over a longer period of time.